Administrative Core

The Administrative Core will manage the overall operations of the center, and will be responsible for coordinating the activities of the various components to promote the cohesive functioning of the center as a whole. This will include monitoring progress on all projects, and scheduling the allocation of other core resources (Recruitment/Screening Core, Education Core), to ensure their efficient use while maintaining a steady demand on these resources. The administrative core will also monitor and control expenditures of all center projects as well as handle budget projections. In addition, this core will coordinate interactions with the Extemal Advisory Committee and the Data Safety Monitoring Board. Moreover, the Administrative Core will organize monthly meetings of the Executive Committee, consisting of Project Directors (PDs), Core Directors (CDs), and other key center personnel. These meetings will foster communication among the PDs and CDs and facilitate key decision making activities to guide the center's progress to achieve our scientific and training objectives.

Public health relevance
Cigarette smoking is the leading preventable cause of disease and death in the U.S. This health burden can be reduced substantially by quitting smoking, and yet current smoking cessation treatments have only limited effectiveness. By coordinating the activities of the center, this core will promote the goals of developing more efficacious smoking cessation treatments and communicating this knowledge to the community. This in turn will have a major positive impact on public health.